Extracellular Matrix Impacts Angiogenesis and Growth Plate Repair

PROJECT SUMMARY
Growth plate injuries, which account for 30% of all pediatric fractures, can impair bone growth and even halt it
completely. For children who are still growing, these injuries can be devastating. The growth plate (or physis) is
a cartilage region found at the end of all long bones in children and is responsible for longitudinal bone growth.
It is a weak area of the developing skeleton and prone to injury. Once damaged, cartilage tissue within the growth
plate can be replaced by unwanted bony tissue, forming a “bony bar”, which can lead to angular deformities or
complete growth arrest. Pediatric patients who sustain these injuries may require multiple surgical interventions
during childhood. Innovative treatment strategies that prevent initial bony bar formation, thus avoiding growth
deformities and potential lifelong disability, are critically needed. The goal of this project is to develop clinically
useful treatment strategies for growth plate injuries that prevent bony bar formation and associated growth
problems. One approach is to target mechanisms responsible for unwanted bony repair tissue, which include
angiogenic signaling pathways. These pathways are regulated at many levels and can be modulated by insoluble
cues such as extracellular matrix factors. The modulation of these cues via a material-only system could provide
significant benefit to ultimate translation of such a regenerative therapy. Our hypothesis is that targeted disruption
of angiogenic signaling cascades after growth plate injury through insoluble cues such as extracellular matrix
factors will inhibit angiogenesis and completely prevent bony bar formation. We will examine this with the
following 2 aims: AIM 1: To quantify the impact of hyaluronic acid (HA) on the angiogenic response that occurs
after growth plate injury. As HA is known to be important in angiogenic signaling, but as its effect can be varied
in different physiologic settings and as its impact in the growth plate after injury has not been studied, here we
will investigate varying molecular weights of HA. Angiogenesis and bony bar prevention will be evaluated in our
rat model of growth plate injury using bulk RNA-seq, microCT, immunostaining and histological assessment. AIM
2: To quantify the impact of specific peptide sequences on the angiogenic response that occurs after growth
plate injury. Here 4 different peptides with established inhibitory effects on angiogenesis and osteogenesis will
be covalently linked to our alginate hydrogels to study their influence on cell behavior. This Aim will quantify the
impact of these peptides on angiogenesis, osteogenesis, and chondrogenesis in vitro and on the angiogenesis
and osteogenesis that occurs in vivo in a rat growth plate injury model, as quantified using bulk RNAseq, microCT,
immunostaining, and histological assessment. This project will provide important information about the impact of
extracellular matrix cues in de novo growth plate injury healing and bony bar formation, supporting the
development of novel biomaterial-based approaches to preventing bony bar formation. Ultimately, we will
translate the technology to larger animal models of growth plate injuries, and eventually into the clinic. This
research will help address a critical unmet clinical need for children suffering from growth plate injuries.

Public health relevance
NARRATIVE The growth plate (or physis) is a cartilage region at the end of all long bones in children that provides signals for bones to lengthen during development; when injured, bony tissue can form in the growth plate, resulting in a “bony bar” that can cause deformities or even completely halt bone growth. This project aims to investigate the development of biomaterial systems that are capable of blocking the angiogenic processes that contribute to the formation of the bony bar. The impact of the extracellular matrix environment on this process will be investigated through the modification of the biomaterial delivery systems with anti-angiogenic peptides and extracellular matrix molecules.